Leadership and Administrative Core

The overarching objective of the Leadership and Administrative Core (LAC) is to advance the scientific
knowledge base of multifactorial geriatric conditions. The LAC, which is led by two board-certified geriatric phy-
sician investigators with complementary expertise, is responsible for strategic planning, organization, adminis-
trative operations and evaluation of the OAIC research and training program. A special effort is devoted to en-
suring the cohesion of the Center and maintenance of an interdisciplinary and translational research focus on
the common research theme, which is the investigation of multifactorial geriatric conditions. The key LAC tasks
are achieved by the Core Leader (Dr. Thomas Gill), Co-Leader (Dr. Terri Fried), two Administrators, and three
committees: the Executive Committee, the Internal Advisory Committee, and the External Advisory Committee.
The LAC has gained much experience, knowledge, and understanding of OAIC operations over its 30 years of
continuous funding, including the past 20 years under the P30 mechanism. We will build on the strong existing
collaborative relationships and cumulative expertise as we enter our next funding cycle.
The Specific Aims of the LAC are to: (1) oversee the coordination, integration, and administration of all as-
pects of the OAIC, including the utilization of core resources, and foster collaborations with other research and
training programs that will help to accomplish the OAIC goals; (2) promote the conduct and dissemination of
academically productive, innovative, high impact, and clinically safe research by REC Scholars, other early-
stage investigators, Pilot/Exploratory Studies (PESs), Resource Cores, and External Projects; (3) ensure the
independent review and oversight of OAIC research and the training of REC Scholars and other early-stage
investigators; (4) foster the career development of junior faculty and other trainees from multiple disciplines into
independent investigators and academic leaders in aging research; (5) recruit and encourage outstanding
early-stage investigators, along with more senior faculty, to focus their research on aging, particularly multifac-
torial geriatric conditions, with an emphasis on translation between basic and clinical research; (6) identify and
facilitate productive collaborations with other OAICs and institutions; and (7) monitor university, government
and fiscal matters, ensure the preparation of necessary progress reports and administrative documents relating
to the award, and collaborate with the NIA project office and Coordinating Center on OAIC activities.
Taken together, the LAC provides support for planning, organizational, evaluation, and administrative activities
relating to the other Cores and to the OAIC as a whole. The LAC is responsible for monitoring, stimulating,
sustaining, evaluating, and reporting progress toward the overall goals of the Yale OAIC. During the next fund-
ing cycle, an important new priority will be the promotion of outstanding translational geroscience research.